Administrative Core

Project Summary – Core A
The essential services provided by the Core include: administrative support for all of the investigators in each
project and core;; fiscal management and oversight for all components of the Program Project;; and
organization and communication of all Program Project meetings and activities. The overall goal of this
Core is efficient stewardship of the P01. The roles of the Core Director and administrative staff are to
facilitate communication while stimulating scientific and technological interactions. This will be achieved by 1)
Establishing an administrative structure to provide support and management for all Program Project
activities. 2) Fostering collaborative research, and 3) Ensuring compliance with regulatory and
governmental guidelines. Overall, The Administrative Core A of this Program Project is designed to provide
scientific leadership, effective communication and an administrative support structure to ensure the
coordination of all Program Project activities.